Development and optimization of highly effective treatments in patients with head and neck cancer using in situ implantable microdevices

The ability to predict the optimal therapy for an individual patient is a major unmet need in the treatment of cancer
and other diseases. The majority of therapies in clinical cancer treatment, particularly cytotoxics and
immunotherapies as well as combinations of multiple drugs, have no reliable predictor of response. This uninformed
therapy selection is highly inefficient and likely leads to reduced therapeutic success rates, increased side effects and
excessive economic expenditures. We have developed a “lab-in-a-patient” implantable microdevices (IMD) which
release spatially discrete microdoses of up to 20 different drugs into locally confined regions of the patient’s tumor,
and measures the response to each localized treatment using a range of histological, immunological, transcriptomic
and other tumor-drug response markers. Each drug-tumor readout measures drug efficacy in a concentration-
dependent manner, and identifies predictive biomarkers of response and resistance directly within each treatment
zone. Our group has developed the IMD technology from ideation through prototyping, animal testing and into early
clinical testing, where the IMD has been tested for safety and feasibility in eight cancer types and across multiple
institutions. We have shown in two landmark publications that IMD readouts may be capable of predicting responses
to chemotherapy in glioblastoma patients, and that IMD readouts are capable of predicting immunotherapy
responses in breast cancer models and can be used to efficiently screen for novel and highly effective therapies. This
project proposes an academic-industrial collaboration which builds on the technical and early clinical advances made
to date, in order to transition the IMD technology from a demonstration of possibility to a status useful for therapy
selection and patient stratification in the clinical oncology and drug development setting. We will conduct a clinical
study in head and neck squamous cell carcinoma (HNSCC) patients that serves to validate the performance of the
IMD in a statistically significant cohort to effectively predict patients’ clinical response to first and second line
immunotherapy and chemotherapy. This data will be pivotal towards regulatory approvals and broader clinical
uptake of the technology which will be led by our commercial partner Kibur Medical. Secondly, we will use several
reservoirs of the IMD to test key in situ pharmacodynamic properties of a novel antibody cytokine conjugate
(provided by our industry collaborator Scare, Inc.) directly in patients with HNSCC, in order to dramatically expedite
the development of this potentially game-changing treatment class. This aim validates a key aspect of successful IMD
commercialization, namely the ability to serve as a platform for early in vivo testing of novel drug candidates, and
will serve as a blueprint for uptake by other drug developers. Thirdly, we will enable clinical use of the IMD in harder-
to-reach lesions in order to make the platform suitable for end users across a broad range of cancer types. Taken
together, the proposed project spans technical, translational and regulatory development that support broad clinical
deployment and commercialization of the IMD technology.

Public health relevance
Project Narrative: Identifying the optimal therapy for a given patient is a major unmet need in cancer and other diseases. We are developing a technology consisting of implantable microdevices that combine microdose delivery of 20 different drugs into spatially distinct regions of a patient’s tumor, with a readout of tumor-drug response for each treatment. The technology provides an empirical approach to identify effective treatments on the pathobiological response observed in the patient, and provides a mechanism to safely and efficiently develop novel drug candidates in a personalized manner.